IGF::OT::IGF IMMUNOGENICITY OF NONAVALENT HPV VACCINE ADMINISTERED PRIOR TO LIVING DONOR RENAL TRANSPLANTATION IN ADULT WOMEN: A PROSPECTIVE, SINGLE-ARM, MULTI-CENTER CLINICAL TRIAL

The contractor will conduct a prospective single-arm trial to evaluate if the nonavalent HPV Gardasil 9 HPV vaccine induces and sustains an adequate immune response at 12-months post-transplantation among 18-49 years old female living donor kidney transplant recipients when ≥ 1 doses of the vaccine are administered ? 30 days prior to transplantation.